Retail Food Safety Regulation Association Collaboration (U18) [Clinical Trial Not Allowed]

Project Summary/Abstract
The National Association of County & City Health Officials (NACCHO) comprises of nearly 3,000 local
health departments (LHDs) across the United States. NACCHO strives to protect and improve the health of
all Americans by assisting and engaging LHDs in promoting national public health policy, developing
resources and programs, seeking health equity, and supporting effective local public health practice and
systems. An integral piece of this mission is devoted to food safety, achieved through NACCHO's promotion
around the role of LHDs in food safety regulation and contributing toward an integrated food safety system,
in collaboration with federal and partner agencies. NACCHO's proposal will be accomplished by
collaborating with the Conference for Food Protection (CFP) and coordinating with the Retail Food Safety
Regulatory Association Collaborative (Collaborative). The Collaborative members have submitted a
coordinated set of funding applications, including constant ongoing coordination between the associations
across the proposed projects. NACCHO's and CFP's proposed three-year initiative lays out the six aims of
the Collaborative to advance state, local, tribal, and territorial (SLTT) retail food protection programs and
reduce foodborne illness. These include the following aims led by NACCHO and CFP: (1) improve the
approach, competency, and food safety culture in the regulatory community; (3) increase enrollment,
engagement, and conformance in the Voluntary National Retail Food Regulatory Program Standards
(Program Standards); and (4) increase the number of establishments that have well-developed and
implemented Food Safety Management Systems (FSMS). The aims will be achieved through Collaborative
workgroup efforts, environmental scans, key informant interviews, focus groups, establishing a Retail Food
Alliance, quantitative and qualitative research methods, educational curriculum/training development, and
utilizing communication channels to communicate the Collaborative's joint messages and resources. The
Retail Food Safety Advisory Group (SLTT program representatives from diverse geographical locations and
jurisdictional sizes) and Collaborative will inform the three-year initiative to provide direction and feedback
on project activities. Under the guidance of these groups and FDA, NACCHO, and CFP will develop tools
and resources essential for SLTTs to improve retail food safety programs and reduce foodborne illness. The
plan will also allow NACCHO and CFP to share strategies on successful adoption of the latest Food Code
editions, implementation of effective intervention strategies, application of effective risk-based inspection
methods, conformance to the Program Standards, and other Collaborative efforts based on the endeavors
of innovative leaders engaged through this initiative.

Public health relevance
Project Narrative According to the Centers for Disease Control and Prevention, consuming contaminated foods is the annual cause of 47.8 million illnesses, 128,000 hospitalizations, and 3,000 deaths just in the U.S., more than half of foodborne illness outbreaks are associated with food from restaurants. More than 3,000 state, local, territorial, and tribal (SLTT) agencies have primary responsibility to regulate the retail food and foodservice industries in the United States. If this project is funded, NACCHO and CFP will work collaboratively with the Retail Food Safety Regulatory Association Collaborative to further the capacity of SLTT agencies to improve retail food safety and reduce foodborne illness across the U.S.